Can an Evidence-Based Mental Health Intervention be Implemented into Preexisting Home Visiting Programs using Implementation Facilitation?

PROJECT SUMMARY
Perinatal mental health conditions are the most common complication of pregnancy and childbirth (1 in 8
women). When left untreated, perinatal depression and anxiety adversely affects the entire family. Significant
racial/ethnic, rural/urban, and socioeconomic status disparities exist in the diagnosis and treatment of perinatal
depression and anxiety and these inequities are often intersectional. Our previous and extensive work with
multilevel stakeholders including well-established community advisory boards, underrepresented and minority
birthing people in rural geographies, and state departments of public health demonstrates the importance of
social support as a mechanism for reducing disparities in perinatal depression, particularly in rural
geographies. Home visiting programs (HVPs) can provide the social support needed to improve mental health
outcomes in pregnant and postpartum women. Despite the known benefits of HVPs and the high rates of
moderate to severe depressive symptoms among HVP recipients, home visitors report that clients with
depression are more difficult to engage; a specific need exists to address perinatal mental health in HVPs.
Mothers and Babies, trialed in HVPs by our co-investigator, is an evidence-based cognitive behavioral
intervention that has been shown to be effective in reducing depressive symptoms, but barriers remain for
maximizing adoption and fidelity within HVPs. Using an evidence-based implementation strategy that tailors
implementation delivery to the needs of the specific populations and context may improve fidelity and adoption,
particularly in rural states where residents have limited access to care. Our long-term goal is to improve uptake
of an evidence-based maternal mental health intervention to reduce disparities in adverse maternal outcomes
and improve community health. The objectives of our study are: Aim 1: Adapt implementation facilitation to
support uptake of Mothers and Babies using stakeholder input; Aim 2: Analyze the effects of the adapted
facilitation on implementation outcomes (i.e., adoption and fidelity) using mixed rapid ethnographic methods;
and Aim 3: Determine the effect of adapted facilitation on the clinical outcomes of severity of depressive
symptoms and perceived stress. We will conduct a hybrid implementation-effectiveness-context cluster
randomized control trial to test the adapted facilitation strategy compared with implementation as usual (i.e.,
standard education) and will examine the mechanisms of change (i.e., contextual determinants) related to
outcomes. The immediate impact of this research will be to show whether adapted facilitation can improve the
uptake and fidelity of a maternal mental health intervention like Mothers and Babies across multiple HVP
models and thus positively affect depressive symptoms and perceived stress of recipients. Further, our
implementation protocol can be used by other states to better integrate other maternal mental health
interventions into HVPs, leading to further improvements in maternal mental health and further reductions in
adverse outcomes for mothers, children, and families.

Public health relevance
PROJECT NARRATIVE Depression and anxiety during and after pregnancy are common medical complications contributing to a rising maternal mortality rate. Home visiting programs can offer evidence-based interventions to improve mental health outcomes for a vulnerable pregnant population; however, barriers remain to achieving the full potential of these interventions. Our work will explore the impact of context on the implementation of a mental health intervention to provide action-based and impactful data that focuses on the lived experiences of the diverse populations served by home visiting programs in Iowa and Indiana.